Regulation of thymus function and aging by the sympathetic nervous system

Project Summary/Abstract
The thymus is the primary lymphoid organ for T cell development and education. During preadolescence, the
thymus generates a critical lifelong T cell repertoire that establishes peripheral immune surveillance and central
tolerance. However, the thymus undergoes age-dependent thymic involution, a natural and progressive deterio-
ration of thymic structure and functionality, which permits the emergence of infectious and neoplastic diseases
in the elderly. Intriguingly, detailed mechanistic underpinnings behind thymic decline with aging remain incom-
pletely understood. Recognizing the importance of thymus health for longevity and quality of life, our work aims
to explore innovative strategies to mitigate thymic involution. Our previous research has shed light on the signif-
icant influence of the sympathetic nervous system on lymphoid organ (i.e., bone marrow) homeostasis. However,
previous efforts in characterizing the microanatomy and function of SNS circuits within thymic compartments
have yielded ambiguous results. Our approach to address these issues involves a two-pronged investigation. In
the first aim, we will map the intrathymic trajectory of β-adrenergic innervation, the key SNS branch innervating
the thymus. By integrating cutting-edge techniques like optical tissue clearing, confocal microscopy, and single-
cell ATAC-sequencing, we will create a comprehensive spatial map of β-adrenergic nerve distribution relative to
the thymic stromal network. Additionally, we will experimentally modulate β-adrenergic signaling to assess its
impact on thymus structure and function. In the second aim, we will utilize methodological resources obtained
from our first objective, including an in-depth digital pathology framework assessing intrathymic stromal topology,
to investigate the role of β-adrenergic innervation in age-dependent thymic involution. By characterizing the de-
teriorating effects of aging on thymic nerves and evaluating the consequences of β-adrenergic signal loss during
aging, we seek to identify key signals responsible for thymic decline and dysfunction. Finally, we propose to
examine the therapeutic potential of sympathomimetic pharmacotherapy (i.e., β-adrenergic agonists) in delaying
and/or reversing thymic involution in aged mice, thus delivering the promise of pharmacologic interventions to
preserve a functional immune system in the elderly. Overall, this research will illuminate the intricate interplay
between the SNS and thymic parenchyma, potentially unlocking new strategies to combat immune system aging.
By enhancing our understanding of the mechanisms underlying thymic involution, we aspire to improve immune
competence and extend healthy lifespan in the aging population.

Public health relevance
Project Narrative Our proposed research will elucidate the role of β-adrenergic innervation in thymic function and age-related thymic involution, a critical lesion affecting peripheral immunity and susceptibility to disease in the elderly. By employing innovative transgenic mouse models, imaging, and flow cytometry techniques, we will define the localization and functional impact of β-adrenergic signals within normal and aged thymic environments. Our studies bear the potential to uncover novel pharmacological targets promoting thymic rejuvenation in aging populations, thereby improving longevity and quality of life.